SHARE Administrative Core

To address research gaps in alcohol and HIV comorbidity in young people living with HIV (YPLWH), particularly
in Florida, Florida State University’s SHARE Program (Self-management of HIV and Alcohol Reaching Emerging
adults) will synergize senior and emerging faculty across the state, national experts, youth stakeholders and
community partners to address the priorities in RFA-20-009. The proposed Administrative Core (AC) will draw
on a multidisciplinary team of experienced senior researchers, community representatives, and administrators
to set, implement, and evaluate the Program Project’s scientific agenda and ensure efficient administrative and
fiscal coordination of our scientific research and capacity-building initiatives. This AC will be the hub for program
activities and coordination across the projects and resource cores and the over-arching liaison between the
SHARE program and internal and external affiliated entities that collaborate on and monitor our work. Through
the AC, SHARE leadership will maintain our focus on community-engaged innovations in translational behavioral
science to improve HIV and alcohol outcomes in young people (ages 18-29) who are a vulnerable population for
HIV and alcohol abuse with significant health disparities. We will do this in the state of Florida, which has the
highest rate of new HIV infections in the US, and an epidemiology that encapsulates diverse populations across
gender, race/ethnicity, and geography (rural/urban). AC mechanisms are designed to maximize synergy across
the SHARE program and provide a foundation for future research. The AC will create an environment in which
developmentally- and culturally-tailored research on comorbid HIV and alcohol use thrives and in which the
SHARE program serves as a catalyst to scientific, practice, policy, and youth stakeholder communities at the
forefront of the HIV/AIDS epidemic in a state-wide initiative within a state hardest hit by the HIV epidemic.